Administrative Core

PROJECT SUMMARY/ABSTRACT – ADMINISTRATIVE CORE
The Administrative Core of the Nigerian Immuno-Oncology Research (NOLA) program will provide centralized
scientific leadership, expert organizational and administrative management, and systematic support for the
research and capacity-building activities of the program. The core will be led by 3 PIs with complementary expertise
in immuno-oncology (IO) and global cancer disparities, who will share overall authority for the scientific and
administrative decision-making. The core will drive the priorities of the P20 by: 1. assembling a multi-disciplinary
team focused on integrated research in IO and health disparities between Nigerian and US cancer patients; 2.
developing the infrastructure to execute IO/cancer disparities research; and 3. building capacity in Nigeria for
future IO research. The NOLA program’s Nigerian hub will be Obafemi Awolowo University (OAU) in Ile-Ife,
Nigeria, the core site for the African Research Group for Oncology (ARGO) consortium. ARGO was founded in
2013 and is now at the center of multiple NIH/NCI grants and training initiatives, with 26 affiliated Nigerian
institutions. The Administrative Core will leverage our extensive experience in coordinating multi-institutional
research studies and building research capacity in Nigeria to foster engagement and productive collaboration,
organize NOLA communications and presentations, oversee program evaluation, support data management and
sharing, and coordinate mentorship. Through these efforts, the Core will play an essential role in creating a
strong foundation for IO research beyond the P20 project period.